Mechanisms of Nucleic Acid Immunogenicity

Project Summary/Abstract
The proposed research seeks to elucidate the structural and mechanistic basis of RNA-dependent innate
immune antiviral proteins regulation that stop translation to curb viral infection. The proposal employs a
synergistic combination of structural biology (X-ray crystallography, cryo-EM), biochemical analyses (kinase,
RNA cleavage assay) and biophysical methods (fluorescence polarization, smFRET, calorimetry) to understand
how viral RNA structures inhibit the double-stranded RNA activated protein kinase R (PKR, Aim 1) and the 2´-
5´-oligoadenylate synthases/endoribonuclease RNase L pathway (Aim 2) to escape the immune response, as
well as the mechanism of interferon induced protein with tetratricopeptide 1 (IFIT1) induced translation control
(Aim 3). Completion of the proposed research will not only produce critical insights into host-virus interplay and
host translation control, but will also reveal novel principles of riboregulation. Such in-depth mechanistic
understanding will provide a solid foundation for future work to design functional RNA devices that elicit specific
functions of PKR and OAS/RNase L, with potential applications in the treatment of infectious and autoimmune
and inflammatory diseases that are severe and costly threats to public health. Upon transition to independence,
the research findings from this proposal will form the basis of the candidate’s first R01 funding application.
The candidate seeks to acquire additional mentored research and career development training through a detailed
plan tailored to his specific training deficiencies and proposed research outside of his current expertise. Such
requested training in the mentored phase, wholly funded by the NIH Division of Intramural Research, will enable
him to become a successful principal investigator upon his transition into research independence. The K99-R00
award will provide excellent opportunities for the candidate to acquire concepts and research skills new to him
through a combination of formal course work, hands-on training, and frequent discussions and evaluations with
his co-mentoring team formed of five internationally renowned intramural and extramural scientists. The major
new research skills to be acquired include cryo-EM, smFRET and eukaryotic protein expression. In consultation
with his mentors and advisors, the candidate has developed a detailed career development plan that is tailored
to remedy his specific deficiencies in teaching, mentoring, lab management, and career development skills. The
plan includes a mentoring course followed by mentoring a NIDDK post-baccalaureate assigned to him, a
leadership and management course, and systematic trainings in career development skills including career
counseling and assessment, mock interviews, practice job and chalk talks.

Public health relevance
Project Narrative The proposed work seeks to elucidate the structural and mechanistic basis for the regulation of RNA-dependent innate immune antiviral proteins that control translation to curb viral infection. Completion of the proposed research will not only produce critical fundamental insights into the arms race of host-virus, but will also inform the design of novel therapeutic strategies against rapidly evolving viruses and many chronic diseases, both of which pose severe and costly threats to public health.